CANOE Partnership: Cancer Awareness, Navigation, Outreach, and Equitable Indigenous Health Outcomes

PROJECT SUMMARY/ABSTRACT
The CANOE Partnership: Cancer Awareness, Navigation, Outreach, and Equitable Indigenous Health
Outcomes U19 Cooperative Agreement is proposed in response to the need to improve cancer outcomes for
American Indian and Alaska Native (AI/AN) communities nationally, with an emphasis on the Washington State
(WA) catchment area of the Fred Hutch/University of Washington/Seattle Children’s Cancer Consortium, a
National Cancer Institute (NCI) designated Comprehensive Cancer Center. The proposed work builds on the
Consortium’s substantial community engagement with Tribes and Tribal Organizations over the past 22 years,
beginning with the Spirit of EAGLES Special Population Network in 2002, up to and including an ongoing R01
“
Digital smoking cessation intervention for nationally-recruited American Indians and
Alaska Natives: A full-scale
randomized controlled trial
” (R01CA284687; PI: Bricker) Disparities in cancer outcomes for the AI/AN population
are due to multiple social determinants. Three major sources of these disparities, amenable to intervention, are:
1) behaviors to reduce cancer risk (e.g., smoking cessation), 2) access to appropriate screening by way of
imaging technologies (e.g., appropriate application of chest computed tomography and mammography) and
colorectal cancer (CRC) screening procedures such as fecal immunochemical test (FIT), and colonoscopy; and
3) primary prevention. We propose a multidimensional approach to addressing these sources of disparate cancer
outcomes in partnership with our Tribal and community collaborators at the South Puget Intertribal Planning
Agency (representing the Chehalis, Nisqually, Skokomish, Shoalwater Bay, and Squaxin Island Tribes) and the
Black Hills Center for American Indian Health (Rapid City, SD). Together, we will use community based
participatory research (CBPR) approaches and the Indigenous Cancer Health Equity Initiative Model to
empower and engage Tribes and Tribal organizations through our three research projects. Our Overall Specific
Aims are: 1) Improve rates of cessation of commercial tobacco smoking among a nationally recruited sample of
AI/AN adults (Research Project 1); 2) Improve rates of lung, colorectal, and breast cancer screenings among our
Tribal partner populations in the Consortium’s catchment area (Research Projects 2 & 3); 3)Prepare the next
generation of researchers in Indigenous cancer equity and provide them with resources to obtain preliminary
data to inform future cancer equity research in Indian Country (Pilot Grant Program); and 4) Develop
infrastructure to support equitable engagement of Tribal partners and Indigenous Frameworks in cancer
research. (Administrative and Community Engagement Cores). The overall public health impact of the proposed
work will be high, given the focus on smoking cessation, cancer screenings and vaccinations that altogether will
prevent and control cancers that are highly prevalent and are responsible for a large share of disparate mortality
rates among Indigenous populations. The public health impact of this work will be high, given its focus on
modifiable behaviors and on future generations of Indigenous Cancer Health Equity researchers.

Public health relevance
PROJECT NARRATIVE Establishing the CANOE Partnership as a resource within the infrastructure of the Consortium solidifies our previous efforts into an entity within an ecosystem of success regarding the fight against cancer mortality among our relatives. We anticipate that while this is a significant step toward Indigenous Cancer Health Equity, it remains a beginning to a long journey ahead and look forward to continuing these efforts in partnership with our Tribal and community collaborators, and with NIMHD as a strong partner in a long term relationship with a unified purpose: Achieving equitable outcomes for not only the cancers upon which the current projects focus; those with the highest cost in lives, but eventually across all cancer outcomes and across the entirety of Indian Country.